Molecular mechanisms controlling skin heterogeneity

This project summary pertains to the Supplement. Different regions of the skin vary in their
characteristics such as thickness, pigmentation, innervation, and presence, size and density of hair follicles
and sweat glands, that are reflected in differential responses to injury and disease. While regional
characteristics of the skin are established during fetal development, positional information must be retained in
the skin throughout life to allow for maintenance of regional characteristics and their re-establishment in wound
healing. Positional information resides in the skin dermis, but its molecular basis is poorly understood.
In the parent grant, we proposed to address these questions by identifying candidate factors and
areas of chromatin involved in establishing skin heterogeneity in embryogenesis through single cell RNA-seq
and single cell ATAC-seq experiments on different regions of developing mouse skin (Aim 1). To determine
which of these candidate factors and chromatin areas may also be responsible for maintaining regional skin
heterogeneity in adult life, we are performing the same analyses on the corresponding areas of adult skin. We
hypothesize that epigenetic mechanisms contribute to maintenance of regional skin characteristics. To test
this, we will first identify patterns of DNA methylation and histone modifications that characterize developing
dermis in specific skin regions by carrying out Bisulfite-seq to reveal sites of DNA methylation and CUT&RUN
for histone modifications that mark enhancers and active, repressed, or poised genes. We will then ask which
of these patterns are maintained in adult dermal cells from the same regions (Aim 2). To test the functions of
candidate regulators in directing and maintaining region-specific differentiation programs, we will use inducible
genetic tools to delete the corresponding genes in developing or adult mouse dermis in vivo. Initial analyses
have been focused on DKK2, SOSTDC1, IGFBP4, and TWIST1, that were identified in preliminary studies as
showing regional differential expression in developing mouse and human skin and influence molecular
pathways important in skin development and/or hair growth (Aim 3).
The Diversity Supplement application is based on our subsequent studies that identified the IGFBP
family member IGFBP7 as being more highly expressed in hairless and less hairy compared with more hairy
developing skin. Unexpectedly, in adult dorsal skin IGFBP7 localizes to the arrector pili muscle (APM), an
essential niche for peripheral sympathetic nerves that innervate bulge stem cells in the adult hair follicle and
are required for their activation. Preliminary data from Igfbp7-null mice show that in the absence of IGFBP7 the
APM is disorganized and thicker than in control mice and shows abnormal branching. Based on these data, we
will test two hypotheses in the Supplement: (i) in embryonic skin, IGFBP7 contributes to suppression of hair
follicle development in hairless and less hairy skin regions; and (ii) IGFBP7 plays a separate role in dorsal
hairy skin to control development and/or maintenance of the APM.

Public health relevance
Project Narrative Different regions of the skin vary in their characteristics such as thickness, pigmentation, innervation, and presence, size and density of hair follicles and sweat glands, that are reflected in differential responses to injury and to diseases such as androgenetic alopecia and psoriasis that predominate in specific skin regions. We propose to identify novel mechanisms that establish and maintain skin heterogeneity. Improved understanding of these mechanisms has potential to reveal new therapeutic targets for diseases that affect specific skin regions and have a major negative impact on quality of life; data obtained in this project will also inform strategies for generating specific skin types, including hair follicle- and sweat gland-bearing skin, for reparative skin grafting.